Micro-laminin Gene Therapy for MDC1A

SUMMARY/ABSTRACT
Congenital Muscular Dystrophy 1A (MDC1A) is one of the most severe forms of muscular
dystrophy, affecting children at birth and causing dramatic muscle weakness. There are
currently no therapies for MDC1A that can ultimately impact disease outcomes. MDC1A arises
from recessive loss of function mutations in the LAMA2 gene, which encodes laminin a2, the
predominant a chain of laminin in the extracellular matrix (ECM) of skeletal muscle. The
LAMA2 gene is too large to be packaged into Adeno Associated Virus (AAV) vectors, making
gene replacement for MDC1A impossible with the current gold standard used for clinical gene
therapy. We have engineered a micro-laminin gene therapy that can be used with AAV. The
current studies will optimize the therapeutic strength of this micro-laminin gene therapy
approach by engineering in an additional component to build new muscle strength. These
therapies will then be tested in a model for MDC1A. In doing so, this work will develop a single
AAV-mediated gene therapy treatment for patients with MDC1A that has the potential to stop
and reverse the disease process.

Public health relevance
PROJECT NARRATIVE Congenital Muscular Dystrophy 1A (MDC1A) is a severe form of muscular dystrophy that is present from birth, causing severe muscle weakness and often premature death. This proposal will test the first gene replacement gene therapy for MDC1A that uses a micro-laminin, a functional fragment of the normal LAMA2 gene that causes the disease when mutated. Additional experiments will be done to engineer this therapy to stimulate new muscle growth and strength, with the goal of creating a more curative therapy. This work aligns well with NIH's mission to enhance health, lengthen life, and reduce illness, disability and the public health burden.